The University of Texas Medical Student Training on Aging Research (UT-MSTAR) Program

PROJECT SUMMARY
The University of Texas Medical Student Training in Aging Research (UT-MSTAR) is a new multisite program involving
the four largest medical schools in Texas: UT Health Science Center at San Antonio (UTHSA), UT Health Houston (UTH),
UT Medical Branch at Galveston (UTMB), and UT Southwestern (UTSW). Combined, our schools accept 940 first year
medical students/year, a large proportion from disadvantaged backgrounds. The UT-MSTAR will leverage our institutions’
rich research programs on aging spanning the entire translational spectrum, our well-established inter-institutional research
and educational collaborations in aging and geriatrics, and our prior experience with the MSTAR program to achieve our
objectives: 1) Expose first year medical students to the excitement of ongoing aging research; 2) Encourage medical
students from all backgrounds to consider pursuing, and to plan for, a research career in biomedical, behavioral, social,
clinical, or health-services research areas; and 3) Increase the pool and diversity of physician scientists engaged in research
in those areas necessary to improve the health and independence of older adults and reduce health disparities.
Rationale: The population of older Americans is rapidly growing and becoming progressively more diverse, increasing the
need for complex and innovative geriatric research and medical care. Yet the number of medical school graduates who
select geriatrics is low, and it has become progressively more difficult for clinicians to engage in research. By exposing first
year medical students to high quality and exciting research on aging led by accomplished mentors in a nurturing
environment, the UT-MSTAR will provide an early opportunity for students to develop a genuine interest and skills that will
lead them to select a career in aging research and geriatrics.
Design of the research training program: 20 first year medical students each year will engage in an 8 week intensive, multi-
institutional, mentored summer research training program on aging that entails: completing a mentored research project –
typically a freezer study or secondary data analysis; group didactic activities, including responsible conduct of research,
topics in aging research, basic statistics, reproducibility, scientific writing and presentations; attending select seminars on
aging research and geriatrics; clinical exposure to geriatric patients by shadowing geriatricians and clinician-investigators
in aging; and presenting the project at the UT-MSTAR annual consortium meeting and at a national conference on aging.
Intended trainee outcomes. We expect students to learn basic research skills, methodologies, and technical expertise in
aging research, increase their positive attitude and perceptions towards caring for older adults, develop a long lasting
connection with their mentors, and eventually pursue a career in aging research.

Public health relevance
NARRATIVE – PUBLIC RELEVANCE With a dramatically increasing number of aged individuals expected to reach more than 20% of the US population by 2050, there is drastic need to identify and develop approaches to improve health in aging. To achieve this goal, we will need to develop a strong group of young clinician-investigators highly motivated and trained in aging research. This training grant will provide a short-term training experience on aging research for 1st year medical students to entice them to eventually pursue a career in aging research and gerontology.